Wisconsin Opioid Prevention and Treatment Research Network (WI OPTRN)

Wisconsin Opioid Prevention and Treatment Research Network (WI OPTRN) Abstract
The opioid overdose crisis remains a major public health emergency, causing over 81,000 deaths in 2023.
Emergency departments (EDs) are key settings for intervention, as they frequently treat individuals with opioid
overdoses or those at high risk for overdose. Despite this, evidence-based practices such as ED
buprenorphine initiation and linkage to ongoing care remain underutilized, representing a significant gap in the
continuum of care for individuals with opioid use disorder (OUD).
A multidisciplinary team, including addiction specialists, emergency medicine physicians, peer support
specialists, human factors engineers, data scientists, and implementation scientists, seeks to address this gap
by improving buprenorphine adoption in EDs. The team will use advanced data-driven methods embedded in
the electronic health record (EHR), combined with peer-supported care continuity. Surveys of ED clinicians at
two University of Wisconsin EDs revealed that clinicians reported that clinical decision support would be a key
facilitator for initiating buprenorphine. In response, a clinical pathway for buprenorphine initiation was
implemented in 2023, but a follow-up evaluation showed that only 23% patients whose ED visit had a
diagnosis of opioid use disorder or opioid overdose received buprenorphine, indicating missed opportunities.
To address this, the team proposes an approach integrating artificial intelligence (AI), EHR-embedded clinical
decision support (CDS), and peer navigation to improve buprenorphine initiation and linkage to care. The team
brings expertise in addiction medicine, implementation science, human-centered design, and clinical
informatics, along with input from a Community Advisory Board (CAB) of people with lived experience.
The project has three aims. Aim 1 will validate the Opioid AI Screener, a tool previously validated in inpatient
settings, to identify patients at high-risk for OUD in the ED with greater than 85% sensitivity and specificity
(years 1-4). Aim 2 will involve co-designing and implementing an EHR-embedded CDS to increase
buprenorphine initiation in the ED. This system will prompt clinicians when high-risk patients are identified, and
offer step-by-step guidance for buprenorphine initiation, management, and automated referral to an outpatient
substance use disorder clinic (Years 1-4). Aim 3 will focus on strengthening linkage to community-based OUD
care through peer support specialist (PSS) navigation. PSS will conduct outreach, help patients find follow-up
care, and address barriers to treatment engagement (Years 1-4). The overarching goal of this project is to
create an implementation guide to support wider adoption of buprenorphine initiation in EDs, improving patient
outcomes and contributing to broader overdose prevention efforts.

Public health relevance
Wisconsin Opioid Prevention and Treatment Research Network (WI OPTRN) Project Narrative The opioid overdose crisis is a continuing public health emergency, yet many patients who experience an overdose are transported to the Emergency Department (ED), where clinicians are generally unprepared to diagnose opioid use disorder, initiate buprenorphine treatment, or provide connections to community-based care. To address this concern, the project team is proposing a comprehensive approach that integrates Artificial Intelligence, Emergency Health Record-embedded clinical decision support, and peer navigation to increase rates of buprenorphine initiation in the ED and successful linkage to community-based care. The project team includes experts in AI research, medications for opioid use disorder, emergency medicine systems improvement, and in clinical informatics.